NUCLEAR MAGNETIC RESONANCE (NMR) INSTRUMENTATION

BEIP continues to explore and support the numerous research opportunities presented by the in vivo application of nuclear magnetic resonance. Work has focused on four main areas: 1) the design and construction of specialized radio frequency coils which have a highly homogeneous -irradiating field, and which, in conjunction with a specialized preamplifier and transmitter, give a constant, high sensitivity signal while probe loading changes; 2) the development of new spinmassaging techniques, in particular, the application of noise pulses with a surface coil to produce rapid spatial localization; 3) the development and implementation of v various echo-planar imaging techniques--a method which aims to produce images in under lOOms--using a new gradient coil design, and 4) the support and improvement of the VAX, SUN, Macintosh and Bruknet computers via networking and the addition of new software.